Third Generation Polygenic Score for Chronic Kidney Disease

Abstract:
Polygenic scores combine small effects of GWAS risk variants across the genome to improve personalized risk
prediction. The first-generation polygenic scores consisted of simple sums of risk alleles at significant GWAS
loci and showed only modest associations with disease risk. The second-generation scores used genome-wide
approaches to improve risk prediction by harnessing extra information from non-significant GWAS loci.
Genome-wide polygenic scores (GPS) for several complex traits have now been shown to exhibit clinically
actionable effects motivating similar approaches for CKD. Recently, we developed and validated a GPS for
CKD optimized for cross-ancestry performance. The top 2% of the GPS was associated with >3-fold increased
risk of CKD across ancestries, the degree of risk equivalent to a family history of kidney disease. Although
these results are promising, several critical gaps remain. First, there is a need to further improve the predictive
properties of the GPS, and this can be achieved with more powerful GWAS and more sophisticated statistical
methods. Second, the clinical utility of the GPS continues to be limited by partial cross-ancestry transferability.
This problem can be addressed by incorporating larger and more diverse GWAS, enhanced models of
ancestry-specific loci (e.g. accounting for pN264K in APOL1), and novel statistical methods aimed at improving
portability. Third, polygenic effects are context-dependent, thus there is a recognized need to evaluate GPS
performance across diverse clinical contexts. Forth, there are no validated integrated models for CKD that
combine polygenic, monogenic, family history, and clinical risk factors into a unified CKD risk stratification
framework. In this proposal, we aim to formulate a third-generation GPS for CKD and address the above gaps
in order to accelerate clinical implementation of polygenic prediction in nephrology. We propose to model
polygenic risk with the latest multi-ancestry GWAS for renal function involving 3.4 million individuals, and
externally validate the new GPS in large ancestrally diverse testing cohorts. We will test the GPS across
heterogenous clinical contexts, including in the setting of monogenic kidney disease, glomerular disease, and
kidney transplant. Lastly, we will develop and validate an integrated genomic risk score for CKD using a
population-based cohort of 20,000 eMERGE-IV participants and the Columbia CKD Biobank cohort of 10,000
CKD patients. Our team benefits from the existing infrastructure for efficient genetic analyses, access to all
relevant datasets, and first-rate local genotyping, bioinformatic, statistical and computing resources, thus we
are ideally positioned to make this project successful.

Public health relevance
Narrative: This new application aims to develop and validate a polygenic score for kidney disease based on a new genome-wide association study of 3.4 million individuals. The proposal will test the role of the new polygenic risk score across multiple ancestries and clinical contexts, including in monogenic kidney disease, glomerular disease, and kidney transplant, and will accelerate clinical applications of polygenic prediction in nephrology.